Listening effort and audiovisual speech by L1 ("native") and LX ("nonnative") English speakers

Project summary
One of the most robust findings in the speech literature is that listeners can understand speech
more successfully when they can see as well as hear the talker. However, there is considerable
debate about whether seeing a talker’s face increases or decreases the cognitive and attentional
requirements for successfully processing speech (“listening effort”), relative to hearing alone.
Conflicting findings in the research may be due, in part, to a lack of systematic evaluation of
multiple factors that moderate the effects of visual input on listening effort. The proposed
research, which will involve undergraduate researchers at every step of the process, will clarify
how audiovisual speech affects multiple facets of listening effort and will assess whether and
how these findings are moderated by the difficulty of the speech task. Further, it will assess
whether these findings extend to participants who have historically been excluded from speech
research: those for whom English is not their first language.
The studies will:
1) Evaluate the consequences of audiovisual speech on listening effort, as quantified by
three commonly-used measures of effort: subjective effort, dual-task costs, and recall.
2) Assess the moderating effect of signal-to-noise ratio on the effort associated with
processing audio-only and audiovisual speech.
3) Evaluate how the language background of the listeners affects the effort associated with
processing audio-only and audiovisual speech.
This will be the first study to assess whether and how the listening effort associated with
processing audiovisual speech differs for people who learned English before any other language
and those who learned another language before English. Given the ubiquity of audiovisual
speech and the fact that maintaining high levels of listening effort can lead to mental fatigue or
distress, understanding how visual information affects listening effort has important practical
and clinical consequences.

Public health relevance
Project narrative The proposed work will assess how seeing a talker’s face affects the cognitive resources necessary to understand speech. Given the ubiquity of audiovisual speech and the fact that maintaining high levels of listening effort can lead to mental fatigue or distress, understanding how visual information affects listening effort has important practical and clinical consequences. This work will assess the nature of these findings in participants who learned English before another language (L1 listeners) and those who learned another language first (LX listeners), to evaluate whether and how “native speaker” status affects the effort necessary to process audiovisual speech.